Administrative Core

PROJECT SUMMARY/ABSTRACT
The overall objective of the Tuskegee University Center for Biomedical Research/Research Centers in
Minority Institutions (TU CBR/RCMI) Program is to build upon and develop the University’s research
infrastructure and researchers to conduct research related to health disparities. This initiative is centered
around: 1) providing the necessary infrastructure, resources, services, and technical support to enhance
the ability of the University’s researchers to stay on the cutting-edge of multidisciplinary biomedical research
focused on health disparities and 2) supporting the research and career development of junior- and mid-level
investigators. These objectives are to be achieved primarily through the following aims: 1) Provide pilot-level
funding to support the development and expansion of the biomedical research capacity of TU; 2) Provide
core research facilities equipped with the infrastructure, instrumentation, and personnel to support the
needs of the TU research community; 3) Engage the community through RCMI-sponsored activities that
include the research faculty; and 4) Provide mentorship and career guidance to enhance the transition of
junior-level investigators into independent scientists. The overall goal of the CBR/RCMI project (2017-2022)
is to continue the development of its infrastructure and increase the numbers and skill proficiency of minority
scientists engaged in advanced biomedical research focused on health disparities, including those for HIV,
obesity, and prostate cancer, all of which disproportionately affect African Americans and
underrepresented minorities. In other words, the goal is to continue support for a competitive, multidisciplinary
collaborative environment that advances biomedical research. Tuskegee University has distinctive strengths
because it is located in the heart of the Southeast, a region with a large, historically underserved, African
American population, and it has a large number of minority faculty members as well as undergraduate and
graduate trainees. The goal of the CBR/RCMI will be accomplished through establishment of three synergistic
research cores, with services to enable investigative research on health inequities among minority groups,
especially African-Americans residing in the ‘Black Belt’ counties of Alabama. These cores create a stimulating
environment that promotes a culture of efficient and timely administrative support that will increase the number
of funding submissions and/or acquisitions of extramural funding in biomedical and community engagement
research. The Administrative Core will provide multi-functional support through pre- and post-award services;
implementation of objectives, directions, and guidance; and oversight to ensure that specific aims and
objectives are accomplished. Additionally, the Investigator Development Core will support the development of
additional areas of research while enhancing the growth of junior faculty through senior mentorship and
bioethics training. Further, through our community engagement core, we will establish relationships, build trust,
and engage local communities and community-based organizations to learn from and to educate community
members on health issues that affect them. We will also implement an evaluation plan to assess, over a period
of five years, the progress, productivity, and accountability of the CBR by using both formative and summative
outcomes. The outcome is to increase, by an approved and enforceable protocol that focuses on junior faculty
development and productivity, the number of R-type grants awarded and the number of publications in peer-
reviewed journals. The availability of advanced research equipment, coupled with the new knowledge
generated by TU PhD students, scientists, and collaborators will contribute to the reduction of health disparities
in the Black Belt counties of Alabama.

Public health relevance
PROJECT NARRATIVE (Overall) This RCMI U54 application is from the existing, successful Tuskegee University (TU) Center for Biomedical Research Program that is committed to the elimination of health disparities in racial/ethnic minority and underserved populations in the ‘Deep South’, particularly among African Americans. By leveraging the distinct location of the center in the Alabama Black Belt and the historical mission of Tuskegee University dedicated to the education of minorities, we are uniquely positioned to develop a cadre of underrepresented minorities that are interested in pursuing research careers in basic biologic, behavioral, and community-based research, while simultaneously supporting research projects that are proposed to understand the causes for these health disparities.